Core B: Assay & Cell Models Core

ABSTRACT
The Assays & Cell Models Core (Core B) provides resources for in vitro testing of CF drug candidates
identified by high-throughput screening (Core A). Core B performs electrophysiological and optical assays of
ion channel and transporter activity, and epithelial cell function, in CF-relevant cell models. The assays use
immortalized cell models and primary airway cell cultures from human sources that are generated and
provided by the Core. In addition, Core B generates new cell lines to enable screening assays. The assays
supported by Core B are critical to the advancement of projects on both pulmonary and non-pulmonary CF
diseases manifestations. Core B interfaces directly with all other Cores in the Center, for instance by testing
focused analog libraries generated by the Chemistry Core (Core C) in order to prioritize compounds for testing
in rodent models (Core D). The most heavily used assay in Core B is measurement of short-circuit current.
Other major Core B assays include optical measurements of CF-relevant airway properties, including airway
surface liquid (ASL) volume and ionic content (pH, [Cl-], [Na+]). The resources supported by Core B are also
available to advance basic and translational research projects on CF pathophysiology at UCSF. Of the 23
projects in the research base, it is anticipated that at least 15 will use Core B resources. The reimagined
Assays & Cell Models Core will continue to meet ongoing workloads and adapt to requirements of new projects
and research directions.